Admin core for the Studies of Physiologic and Pathologic Platelet Plug Formation

CORE A: ADMINISTRATION
Core A, the Administrative Core, is essential for the conduct of the Program Project. Core A is
based in the administrative area of the Hematology-Oncology Division at the University of
Pennsylvania and is located on the 8th floor of the Biomedical Research Building II/III. Core A will
provide administrative support for the participants in the Program Project, as well as secretarial,
and consultative functions and the supplies needed to support these functions. Core Unit A will
provide two types of consultative function. First, outside investigators whose interests coincide
with those of the members of the Program Project will be asked to give a monthly seminar, and
meet with the various Project leaders and Co-Investigators. Second, an External Advisory
Committee composed of three members to be selected if and when the Program Project is funded
will be asked to visit the Program Project on a yearly basis, review its progress, and make specific
recommendations regarding future directions.

Public health relevance
CORE A: NARRATIVE Core A, the Administrative Core, by providing fiscal administration, secretarial support, and consultative functions, is essential for the conduct of the Program Project.